Perm1 is a Novel Regulator of Cardiac Energetics and Function

PROJESCUTMMARYfor parent grant R01HL156667
EnermgeytabroelpircograomcmurisinntgehdevleopaindgiseahseeadrMtist.ochaornedria
respsiobnlfeocroordicnealtlieunnelgragrpyroducintrieosnpotonpsheysiolaongdpiactahlologic
stimuTlhiem.itochornedgruilasaylsttoermiyshighrleygulbaytseedvetralnscrfiapcttiaoonrnds
coactaiotvrtshoartceshtarettehexrpesosnoifgeneisnlvvodeinmitochobnidonrgeiessa,milaintenance
andrespircaaptaciiotnyH.oweveterh,transcrirepgutlaitoonrmayalcihneriynmitochondri
bieonegretiicscsomplaenxid,itsltlnioctompleutndeerlosyodthowmitochocnodrrdianraetseploynd
tophysioalnopgdaitochlagolciasltimuli.
Perm1("PCG-a1ndERRreguliantmoursc1l"ew)asreceindtelnytiniskfeileedmtuaslcalsea,
novmeulsclpeec-ifcsiprottehiarnetgulatmeistochoonxddaitrivacaelpaciPteyr.mi1sinducbeyd
exercainstdhee,increaesxepdresosfPieornme1nhanmcietsochobnidorgieanolexsiidsac,taipvaecity,
andfatigrueesistinamnocuessekelemtuaslclTeh.esfiendipnogistnota newpatthowards
understmaintdoicnhgomnydorpiaatalhnidmeussclaetropHhoiwesv.etreh,roolefPermin1thheeart
hansevbeereinnvestiMgoarteeotdveh.erre,gulmaetcohraynoifPsemrmin1mitochofnnudcrtiiasoln
currenutnlkynowOnur.prelimidantaarsuyggetseht singificraonlotefPermi1ncardiac
pathophy(s1iP)oelromig1shyi:gehxlpyresinstehhdeeaarntdisdownreguilnatethmeodusfeailing
heaarntdinpatiteswnithheafratil(u2rP)ee;rme1xpresissinicorneadsuerdidnigfferenatnidatio
maturainthiumoanniPcSell-dcearridvieodmy(o3cP)yetremks1n;ockdioncwunltcuardiremodyocytes
laedstoreducmeidtochornedsrpiiarclaaptaicoiFnutryt.hermoourrper,elimdiatnasaurgygetshtat
Permc1ontmriotloschofnudnrcitthraiolountghreeguloafEtRiRoana,well-ktrnaonwsncrfiapcttioorn
thatorchestthreeaxtpersesosfgieonneinsmitochobnidoreinaelrgetics.
Thisapplicwialltelvieornaaggeenetaincimmaoldealndsatte-oafr-mttuhletisyapsptreomasch
toconcepatduvaalnlocuyerunderstoafmnitdoicnhgonbdiroieanleringteehtheiacrsStp.eciftihciaslly
woriksexpecttodeedmonstrhaPteermi1sacritriecgaulloafmtiotrochobnidorsiyanlatnhdesis
energeinttihechsearttrhougthheERRapatahy.wFurthertmhoisrsteu,wdiydlelterimfigennee
deliovfPeerrymto1tehheaprrtotaegcatismnisttochoinmdpraiiaralnmdecnatrddiyascfunicntthieon
setintgofpressure-overhleoaarfdta-iilnCudorunecc.elduesviivdeetnhcaePtermi1sa novel
transcrciopftaiocofttneohamrliocthodnrireagullatopraythwiantyehhearwtiplrlfoounaddlvyanocure
knowleofdcgaerdmieatcaboalnidmsamys,uggneeswttherapaepuptriocafcohreasfriautlre.

Public health relevance
PROJECNTARRATIVE for parent grant R01HL156667 TheheacrotnstarnetqluyierneesrtgoyworkM.itochownhdircaihraer,enownaesbdein"gthe powerhofutsheceelslu"p,pcloyntineunoeurtsgotyhceardciealcMlist.ochomnadlrfiuanicstion closleilnytkodeedvelopmenatndddyesffeucnitcntsthiheoenaTrhtia.spplicsaetetikoaosdnvanocuer understoafmnedtianbgroelpircograomftmhhieenagtrhtromuigthochondripaalthwdauyrsing signaling postndaetvaellopamnedpnattholdoegvieclaolpSmpeencti.ftihcipasrlolpyo,wsiaulltlilaigzeenetic modealndstate-of-the-aarptprotaodcehtertmhirnoeloefthneovmeulscle-speci multisystems mitochondriPaelrmi1nmitoch ndriaalndebnieorggeeintnteihshceiessalatnhdyiseased regulator hearts.